IMPACT: Promoting Diversity and the Success of Underrepresented Minority Students in the Clinical and Research Workforce for Communication Sciences and Disorders

Project Summary
The IMPACT (Innovative Mentoring and Professional Advancement Through Cultural Training) Program is a
multi-dimensional, inter-institutional, collaborative mentoring program for underrepresented minority (URM)
students who are interested in communication sciences and disorders (CSD). This program is a collaboration
between Case Western Reserve University (CWRU), a top US research university, and Hampton University
(HU), a top ranked Historically Black College and University (HBCU). CWRU is known for its innovation in
CSD, and it is located in a predominately Black neighborhood. HU has the oldest graduate program in
speech-language pathology (SLP) at an HBCU and has graduated more Black SLPs than any other US
program. CWRU and HU, along with their corporate and institutional partners and many peer supports, will
provide structured mentorship and professional development resources to build broad and diverse
developmental mentorship networks for the 42 and 24 undergraduate and graduate students, respectively, who
will participate in the IMPACT program throughout the five-year grant cycle. The aims of this proposal are to: 1)
build developmental networks for URM students in CSD, and 2) successfully transition students in CSD into
clinical and research graduate programs. By achieving these aims, URM students in CSD will be more likely to
pursue a career in research and the foundation will be laid for a successful research career. IMPACT Fellows
will be paired with academic, research, affinity, and peer mentors, along with writing, wellness, and career
coaches; they will meet regularly with these mentors and coaches throughout each academic year.
Undergraduate Fellows will complete at least 150 hours of learning experiences, while graduate Fellows will
complete a minimum of 50 hours. Work from this five-year proposal will be used to create both a model and a
manual for collaborative CSD mentoring programs between other minority-serving-institutions (e.g., HBCUs)
and research-intensive universities. Long-term outcomes of the IMPACT program include the achievement and
retention of URM students in CSD careers. This in turn is expected to support the broader mission of NIDCD
by improving outcomes for communication disorders in URM populations by fostering diversity of thought,
inclusive assessment, and equitable treatment in clinical CSD research.

Public health relevance
Project Narrative This proposal describes an innovative, collaborative, inter-institutional mentoring program between Case Western Reserve University and Hampton University to support underrepresented minority (URM) students in communication sciences and disorders (CSD). The purpose of this program is to enhance the diversity of the CSD workforce to better serve all people with communication disorders by successfully transitioning URM students to CSD graduate programs and by developing strong networks of mentors to foster long-term success. Over the course of the annual programming, students will advance their professional development skills, build a diverse professional network, increase their sense of belonging in the field, particularly research, increase their knowledge of CSD professions, and enhance their self-efficacy, resulting in increased URM student achievement and retention in CSD.